Rapid learning during a public health emergency: COVID-19 related medication treatment patterns in Medicare

SUMMARY/ABSTRACT
Medical practice is continuously evolving, with substantial resources allocated to developing medical
innovations and enhancing clinical evidence on new and existing treatments. In most cases, new evidence
supporting approval by the Food and Drug Administration (FDA) demonstrates efficacy of new treatments; after
approval, new evidence for existing treatments may show them to be ineffective or unsafe. Understanding
whether and how new clinical evidence is integrated into practice is critical from the perspectives of a)
improving patient safety and health outcomes; b) addressing racial and socioeconomic equity in access and
use; c) designing programs and policies to encourage use of high value, effective treatments and abandon less
effective and harmful treatments; d) containing health care costs by allocating limited health care budgets to
their most effective use.
The COVID-19 pandemic provides a unique opportunity to study the diffusion of evidence into practice by
observing adoption and de-adoption behavior of physicians in response to rapidly changing information about
potential treatments and risks of continued use of common drugs in the context of COVID-19. This proposal
builds on our prior work on de-adoption of harmful or ineffective medical practices by introducing additional
factors that could be associated with the rates and timing of adoption and de-adoption of pharmaceutical
treatments. We will examine prescription fills and claims-based use of a targeted set of drugs related to
COVID-19 using data from Medicare claims for Fee-for-Service (FFS) enrollees. COVID-19 has particularly
affected older adults and the disabled and chronically ill, many of whom face increased risk of severe morbidity
and mortality from the disease, and potentially from lack of access to medical care during the pandemic. We
will investigate how prescribing of COVID-19-related drugs responds to state-level drug policies, FDA safety
communications, and COVID-19 pressures on the healthcare system. We will assess how patient
characteristics (e.g., race and ethnicity, age, and key comorbidities), as well as physician and medical practice
organization characteristics are associated with these prescribing patterns.
Three in-depth COVID-19 case studies will assess uptake and de-adoption of treatments associated with
lower quality evidence and more rapid turnaround in a context where public attention is closely attuned to
every development and pre-print biomedical manuscripts are discussed at length in the popular press.
Exploring adoption and de-adoption of treatments in a context of high uncertainty and high burden and
prevalence of disease will provide important insights into the role of information quality in physician decision
making. In addition, these cases will allow us to explore the effectiveness of state-level regulation of
treatments. In particular, hydroxychloroquine was regulated in some states in response to fears that not
enough would be available for people using the drug to treat non-COVID-19 conditions.

Public health relevance
NARRATIVE This project will examine trends in prescribing and use of COVID-19-related drugs during the time before and after the pandemic among the Medicare population in outpatient setting, describing variation in their use across patients, as well as across physicians and geographic areas. We will also examine, in depth, three case studies of COVID-19-related drugs that received substantial public attention during the early months of the pandemic. We will describe changes in use associated with FDA safety communications and state policies intended to address hoarding; and investigate how use of these drugs varies by patient, physician and medical practice organization characteristics.